Molecular mechanisms that regulate polarity and spindle orientation in animals

Project abstract Funding is requested for the purchase of an AKTA pure 25 protein puriﬁcation system for purifying the reagents necessary for examining the biochemical activity of the Par complex, a key aspect of the parent grant, R35GM127092. To reconstitute and interrogate Par complex proteins to understand the mechanism by which polarity is regulated, highly pure reagents are required. This is challenging for two reasons. First, the Par complex itself is diﬃcult to obtain as it is obtained from transiently transfected cultured cells. Second, our work requires making various modiﬁed forms of Par complex proteins (e.g. truncations) and this instrument will allow us to separate them from impurities with high resolution. We expect that the additional capabilities provided by this instrument will have a signiﬁcant and sustained positive impact on our research program by increasing the reliability and reproducibility of key reagents.

Public health relevance
Narrative This administrative supplement requests funds to purchase a AKTA pure 25 protein puriﬁcation system. We would like to use this instrument to achieve high purity of key reagents we produce while reconstituting the animal cell polarity Par complex. The instrument will have a signiﬁcant impact on our work by improving the reliability and reproducibility of our reagents.